Interhemispheric communication underlying bimanual and eye-hand coordination

ABSTRACT
Primates, including humans, are expert at coordinating their arms and eyes in skillful behavior. Our goal is to
understand the neural circuitry that underlies the combination of bimanual coordination and eye-hand
coordination, which we call “hand-eye-hand” (HEH) coordination. We are particularly interested in the early
planning of bimanual movements, and the role-effector specific areas in the posterior parietal cortex play in that
planning. We hypothesize that inter-areal and inter-hemispheric communication is necessary for HEH
coordination. For example, the parietal reach region (PRR) controls primarily the contralateral arm. One way for
one hand to know what the other is doing, so to speak, is for information to be exchanged between PRR in each
hemisphere.
The most direct pathway for such communication is through the corpus callosum, a major fiber tract connecting
the two hemispheres. The relative accessibility of the corpus callosum provides an opportunity for causal tests of
the role callosum plays in particular, and of inter-hemispheric communication in general, in HEH coordination.
Lidocaine injections can reversibly block conduction through particular portions of the callosum, and behavior
and neuronal activity can be compared in behaving animals before, during and after blockade. We predict that
HEH coordination will be impaired when particular ﬁber tracts within the callosum are blocked, and that there
will be neuronal correlates of that impairment within the brain areas responsible for the behavior.
Our ﬁrst Aim is to establish where in the callosum particular axonal tracts cross, and to verify that we can
reversibly block conduction through those pathways. Next, for our second Aim, we will test speciﬁc hypotheses
regarding which behaviors will be affected when particular pathways are blocked. We will consider pathways to
and from the parietal reach region (PRR) and the lateral intraparietal area (LIP), an analogous area that codes
saccade plans. Animals will perform interleaved, natural unimanual and bimanual reaches and saccades. We
will then, in our third Aim, examine activity within PRR and LIP to determine how speciﬁc neuronal circuits are
impacted by the transient loss of speciﬁc callosal pathways.
Bimanual HEH coordination is critical for normal human behavior, yet the neuronal circuits involved remain
largely unknown. This work will greatly expand our understanding of how parietal cortex achieves complex yet
ﬂexible coordination of body parts. The information will be relevant to coordination in other effector systems,
and will help us design the next generation of brain-computer interfacing prosthetics that can leverage natural
coordination patterns and coordinate with existing limbs and eye movements. Further, we will learn
fundamental facts about the role of the corpus callosum in the brain. Finally, this work will shed light on the
general issue of long range communication across brain areas, and how this communication is related to brain
function.

Public health relevance
PROJECT NARRATIVE The central goal of this proposal is to understand the neural systems subserving coordinated eye and arm movements, and in particular, the role of the corpus callosum, a structure connecting the two halves of the brain. Coordinated movements are central to our daily functions, yet are often compromised by strokes, trauma and degenerative diseases. A better understanding of the brain systems underlying coordination may benefit clinical diagnosis and prognosis in these conditions and eventually lead to improved treatment, including, for example, limb prostheses that support natural coordination with an existing limb or between a pair of prosthetic limbs.